Early Sleep Disruption and Neurodevelopmental Trajectories in Infancy

Abstract
Despite the critical role of sleep in brain development during infancy, little is known about the impact of early
sleep disturbance in typical and atypical development. Sleep disruption occurs in up to 80% of children with
autism spectrum disorder (ASD). A complete understanding of sleep problems in the first year of life will aid in
both the early detection of risk and prompt intervention prior to the onset of symptoms. This project will improve
our knowledge of sleep in infancy by longitudinally examining how distinct sleep metrics, such as sleep latency,
sleep time, and sleep efficiency, relate to functional brain networks and later developmental trajectories.
The proposed study will leverage data from two NIH-funded longitudinal studies to (i) examine how sleep latency
and thalamocortical connectivity may predict diagnostic outcome in infants at varying familial likelihood for ASD
(Aim 1) and (ii) investigate normative trajectories of objectively measured sleep and thalamocortical connectivity
in an unprecedented sample of infants (Aim 2). About 20% of infant siblings of children with ASD will be
diagnosed with ASD themselves, while another 30% will show subclinical ASD symptoms. Thus, studying infant
siblings provides a unique opportunity to examine early ASD markers. Prior work has shown altered functional
networks in infants who later receive a clinical diagnosis. This provides insight into the divergence of
neurodevelopment in these infants, yet the impact of early sleep disturbance on brain networks has yet to be
elucidated. Here, resting-state fMRI and behavioral data from the Infant Brain Imaging Study (IBIS) will be used
to analyze the relationship between sleep, functional connectivity, and ASD outcome. Ultimately, a greater
understanding of sleep in typical development is needed to properly delineate it in neurodevelopmental
disorders. However, there is a paucity of well-sampled, longitudinal studies characterizing typical brain
development in infancy and no study has implemented objective sleep measures in a large population of infants.
The HEALthy Brain and Child Development (HBCD) study is an ongoing longitudinal project that collects
neuroimaging, behavioral, and objective sleep measures from a cohort of ~7,500 infants. In the proposed project,
resting-state fMRI data will be used to relate objective sleep metrics collected through actigraphy to functional
connectivity and clinically assessed behavioral outcomes.
Emily Chiem will conduct these studies as a UCLA graduate student in the Molecular, Cellular, and Integrative
Physiology program. She will receive guidance from her sponsor, who has vast expertise in neurodevelopment,
pediatric imaging, advanced MRI methods, and ASD research, as well as mentors with expertise in pediatric
sleep. The rich sleep and neuroimaging communities, training opportunities, and resources available at UCLA
makes it an ideal training environment. The fellowship support will allow the candidate to receive comprehensive
MRI training, learn advanced data-analytic approaches, improve her mentorship skills and, critically, it will afford
her protected time to focus on her own research thus propelling her independent research career.

Public health relevance
Project Narrative Sleep problems are prevalent in individuals with neurodevelopmental conditions, such as autism spectrum disorder (ASD), which can have deleterious effects on brain development and behavioral outcomes. The proposed studies will longitudinally examine the impacts of infant sleep disturbances on brain connectivity and developmental trajectories in both typical and atypical development. These findings will inform the utility of distinct sleep metrics as an early biomarker for altered neurodevelopment, leading to earlier detection and interventions for neurodevelopmental conditions.